Role of Irg-1/itaconate in modulating secondary brain damage after traumatic brain injury in mice

Project Summary:
The development of a novel therapeutic strategy to effectively target multiple pathological mechanisms of
secondary brain damage after traumatic brain injury (TBI) is a top clinical priority. The metabolic
reprogramming of neurovascular inflammatory cells after TBI may contribute to the cellular
oxidative/neuroinflammatory stresses and play critical roles in the early triggering and acceleration of
secondary brain injury cascades. However, the detailed knowledge remains largely unknown. Recent
experimental discoveries demonstrate that itaconate, one of the most abundant tricarboxylic acids (TCA)
cycle intermediates, produced by an enzyme called immune-responsive gene 1 protein (Irg-1), may function
as a signaling transducer in modulating the metabolic reprogramming. Our central hypothesis is that the Irg-
1/itaconate modulates the metabolic reprogramming and thus controls neurovascular inflammatory signaling
pathways of the microglia and the cerebrovascular endothelium by preserving mitochondria oxidative
phosphorylation (OXPHOS), suppressing hyperglycolysis/NFκB activation, and activating nuclear factor E2-
related factor 2 (Nrf2), which results in the inhibition of microglial activation-associated neuroinflammation,
and blood-brain barrier (BBB) integrity disruption; these actions interactively prevent the secondary brain
damage and ultimately improve the long-term neurological outcome of TBI. Our preliminary data are highly
supportive of our proposed hypotheses and experimental approaches. In this project, we will pursue three
integrated aims using bioenergetics/metabolomics and transcriptomics, functional energy metabolic assay
of brain slices and isolated cells, and in combination with cell-specific transgenic and pharmacological,
molecular pathology, and neurological outcome assessments. In Aim 1, we will investigate the role of
microglial Irg-1/itaconate in the modulation of microglial pro-inflammatory activation after TBI. In Aim 2, we
will investigate the role of cerebrovascular endothelial Irg-1/itaconate in the modulation of BBB integrity after
TBI. In Aim 3, we will investigate the role of itaconate supplementation in long-term neurological outcomes
after TBI in mice. The proposed studies will provide detailed insights into the dynamic
bioenergetics/metabolic reprogramming of inflammatory microglia and cerebral endothelium, elucidate the
role of Irg-1/itaconate in modulating the metabolic reprogramming, and associated neurovascular
inflammatory mechanisms after TBI.

Public health relevance
Project Narrative: Recent experimental discoveries demonstrate that Irg-1/itaconate might be a novel therapeutic targeting molecule for preventing secondary brain damage after traumatic brain injury (TBI). This project will pursue three specific aims to test our central hypothesis: Irg-1/itaconate modulates multiple bioenergetics and neurovascular inflammatory signaling pathways of microglia and cerebrovascular endothelium, including preserving mitochondria oxidative phosphorylation (OXPHOS), while suppressing hyperglycolysis/NFκB activation, but activating Nrf2 signaling pathway, which results in inhibition of microglia activation-associated neuroinflammation (Aim-1), and BBB integrity disruption (Aim-2). These actions interactively prevent secondary brain damage and ultimately improve long-term neurological outcomes of TBI (Aim-3).